Antecedents and Outcomes of Subjective Cognitive Decline: An Electronic Health Records and Artificial Intelligence Approach

PROJECT SUMMARY
Early detection of Alzheimer’s disease and related dementias (ADRD) from electronic health records (EHRs)
can facilitate participant enrollment in clinical trials and early intervention once clinically available. Subjective
cognitive decline (SCD) can be an early manifestation of ADRD. Previous research in early detection of ADRD
has focused on observational study cohorts, generally small in size and often with stringent medical exclusion
criteria. Investigation of larger and more representative samples is needed to develop a full understanding of
the underlying conditions, procedures, and/or interventions that can contribute to cognitive decline or
accelerate progression to dementia in the population at large. The overall goal of this proposed research is to
leverage large-scale EHR data and advanced informatics technology to develop case-finding methods for SCD
and to advance the understanding of its risk factors and dementia outcomes in older adults. Preliminary data
suggest that clinical notes and machine learning (ML) algorithms can be helpful to capture patients with early
cognitive decline. However, identifying which patients with SCD are more likely to develop dementia is
extremely challenging. During the K99 phase, the first aim will be to develop an informatics approach to identify
a pre-dementia cohort (patients with evidence of a cognitive concern but no dementia). The second aim will
identify the social and clinical characteristics of this cohort in the EHR, along with antecedent risk factors, and
predictors for a dementia outcome. The two hypotheses are that 1) clinical conditions (eg, neuropsychiatric
disorders, cardiovascular diseases, renal disease, respiratory infections, sleep disorders) and medications that
deleteriously affect cognition will contribute to the initial appearance of cognitive decline; and 2) longitudinal,
multimodal EHR data can be leveraged in ML models to stratify patients with high risk of dementia. To
accomplish these goals, the applicant will leverage existing strengths in case identification, risk factor
analyses, and prognostic modeling and gain additional knowledge and skills in three critical areas of training:
(1) cognitive decline and ADRD, (2) clinical epidemiology, and (3) statistical methods. With the development of
these skills, the applicant will be well positioned in the R00 phase to conduct the final aim: to study the
antecedent risk factors and outcomes of SCD in a presumed SCD cohort (patients with both a subjective
cognitive concern and normal performance on objective cognitive measures). Similar approaches to those
used in the second aim will be employed to study the presumed SCD cohort. A highly innovative component of
this project is the use of advanced artificial intelligence and large-scale EHR data for presumed SCD cohort
identification, risk factor analyses, and early detection of dementia. The proposed study will provide some of
the first insights into the characteristics and risk factors of SCD in the EHR, and predictors for dementia
outcomes in SCD. For the applicant, this program will support a rapid transition to independence through a
short period of intensive training and mentorship, which will seamlessly intertwine with the aims of the
proposed project.

Public health relevance
PROJECT NARRATIVE This Pathway to Independence Award focuses on leveraging advanced artificial intelligence approaches and large-scale electronic health records (EHR) to study antecedent risk factors for subjective cognitive decline (SCD) and dementia outcomes in SCD. Specifically, machine learning and natural language processing techniques and statistical methods will be used to identify pre-dementia and presumed SCD study cohorts in a large EHR, analyze social and clinical characteristics for potential risk factors for SCD, and predict the risk of dementia progression in SCD. Research results gleaned from these analyses using large, longitudinal EHR data will advance the understanding of the antecedents and outcomes of SCD in EHR, which has the potential to improve the process of participant selection and enrollment in clinical trials and thereafter early interventions for Alzheimer’s disease and related dementias.